Mechanisms of stress-induced neurovascular damage promoting immune infiltration and depression-like behaviors

Multiple clinical studies suggest that heightened peripheral inflammation contributes to major
depressive disorder (MDD) pathogenesis. Co-morbidity of inflammatory disease with MDD is highly prevalent,
and MDD patients have a higher risk of developing those diseases. It has been hypothesized that circulating
inflammatory molecules are released following chronic stress, penetrate the blood brain barrier (BBB), and
affect neural circuits, mediating stress vulnerability and depression. However, despite years of intensive
research into the role of cytokines in depression, we have very little direct evidence of how cytokines enter the
brain and in which circuits they act. Recently, we have begun to investigate the effect of chronic social defeat
stress (CSDS), a mouse model of stress that induces depression-like behavior, on BBB permeability.
Endothelial cells and astrocytes play critical roles in maintaining vascular impermeability. Endothelial cells, via
expression of tight junction proteins, establish the paracellular barrier between the perivascular space and
brain parenchyma. Breakdown of the endothelial barrier can lead to infiltration of peripheral immune signals—
such as IL-6—that we have shown previously to increase stress susceptibility. Our new data shows that 10
days of CSDS downregulates expression of the tight junction protein Cldn5 in the NAc of stress-susceptible
mice leading to loss of integrity of the endothelial barrier, immune infiltration and expression of depression-like
behaviors. Expanding upon these preliminary observations, we will probe the detailed molecular and cellular
mechanisms by which peripheral immune signals interface with mood-related brain circuitry to control
depression-like behaviors following social stress. By understanding how chronic stress affects the BBB we may
be able to augment current antidepressant treatment or design new therapeutic strategies promoting vascular
health by preventing BBB degeneration.

Public health relevance
Major depressive disorder is associated with heightened peripheral inflammation that is casually linked to depression symptoms. Despite years of intensive research and ongoing clinical trials to test antidepressant efficacy of immune modulatory drugs that target systemic inflammation, it is still unclear how the peripheral immune system interfaces with mood-related brain circuitry to control depression-like behavioral responses. In this proposal we show that chronic stress induces neurovascular damage that weakens the blood brain barrier to allow immune infiltration and expression of depression-like behaviors.